Early diagnosis and mechanistic studies of type 1 diabetes using single cell analysis

Type 1 diabetes (T1D), a prototypic CD4 T cell mediated autoimmune disease, is believed to have a prolonged
pre-clinical phase that lasts many years. Therapeutic intervention during that period of the disease has
demonstrated effectiveness in a small subset of patients and for a limited time. However, the determination of a
precise disease status in those patients is a missing parameter for the therapeutic decision. Indeed, outside of
glycemia, and glucose tolerance tests, the only indication of b cell autoimmunity is the measurement of anti-islet
autoantibodies (AIAs). However, AIAs have limited predictive power at the individual level and cannot be used
to evaluate therapeutic outcomes. Thus, real time biomarkers of islet autoimmunity are an absolute medical need
to allow early targeted therapeutic intervention in at-risk populations, evaluate its efficacy, and eventually pave
the way to prevent and cure type 1 diabetes. Because T1D has a strong genetic background and that HLA-class
II genes dominate this landscape, it is logical to position anti-islet CD4 T cells at the center of the early pathology.
In this respect, we hypothesized that if we could measure anti-b cell CD4 T cell immunity, we would have a
biomarker for T1D. We validated this concept in human bearing the high-risk HLA-DQ8 allele. Insulin peptides-
HLA-DQ8 tetramers were produced and used to isolate antigen specific CD4 T cells from peripheral blood. Four
groups of patients were tested, normal blood donors, just diagnosed, established, and at-risk patients. While
frequencies of anti-insulin T cells were uninformative, their state of activation was correlated with disease, and
could determine whether at-risk patients had active autoimmunity or not, regardless of their AIA status. Similarly,
in established T1D patients, autoimmunity was still ongoing. We will expand on these published results in 2 aims.
Aim 1 is the core of the proposal and will evaluate in larger cohorts the profile of activation of anti-islet CD4 and
CD8 T cells in longitudinal studies to correlate T cell activation and progression. These studies should formally
establish or disprove the relapsing-remitting nature of T1D. The same approach has the potential to allow the
monitoring of therapeutic interventions. Aim 2 is focused on mechanistic studies and based on the hypothesis
that anti-islet T cells must have a unique phenotype of activation and homing. This phenotype will be
deconstructed in mice by comparing antigen specific islet-resident T cells and their blood counterparts. After a
step of in vivo Crispr/Cas9 validation, the islet specificity of circulating cells harboring the selected phenotype
will be translated and tested in humans. These studies will illuminate basic aspects of islet-immune system
relationship and could establish new principles of therapeutic intervention.
This ambitious proposal is intended to provide the necessary data to deploy in the clinic a set of tools
that measure anti-islet immunity in real time. This knowledge will guide intervention decisions and help
monitoring treatment of T1D. The same framework and approaches of mouse to human translation that we have
developed over the past 4 years should be generalizable to any other T cell mediated autoimmune disease.

Public health relevance
Type 1 diabetes (T1D), a prototypic CD4 T cell mediated autoimmune disease, is believed to have a prolonged pre-clinical phase that lasts many years. We will use circulating anti-insulin CD4 T cells as a real-time biomarker of islet autoimmunity to diagnose subclinical disease in at-risk population and decide of therapeutic intervention. The proof of principle of this approach has been established in a small cohort of patients enrolled in the TrialNet consortium.